The role of the primary cilium in insulin signaling and common disease pathogenesis

PROJECT SUMMARY
Rare genetic defects of the primary cilium can cause a number of phenotypically-overlapping Mendelian
syndromes, known as ciliopathies. Intriguingly, many ciliopathy patients show signs of impaired glucose
homeostasis, with accumulating evidence suggesting that insulin receptor must be specifically trafficked into the
cilium to initiate insulin-dependent signaling cascades. However, we do not yet know if variants in ciliary genes
increase an individual’s risk for diabetes more generally, nor do we understand the mechanisms by which ciliary
genes might affect insulin receptor signaling to cause pathology. The goal of this proposal is to fill this gap in our
knowledge using complementary bioinformatic and cell biologic approaches. My clinical and scientific expertise
in ciliary biology and human genetics, coupled with my exciting preliminary results, rigorous research plan, and
outstanding mentorship team, provide a solid foundation for this project. In completing the proposed work,
specifically with its focus on providing me additional training in the field of bioinformatics and in lab management,
I will be perfectly poised to begin my independent academic career as a physician scientist seeking to better
understand the genetics and biology of ciliary dysfunction in human disease. I have secured the complete support
of my institution, and will benefit greatly from the unparalleled resources and mentorship available at both the
University of Pennsylvania and the Children’s Hospital of Philadelphia over the course of this award.
I hypothesize that variants in ciliary genes increase risk for diabetes by perturbing cell signaling pathways
essential to normal insulin signaling. My preliminary analyses in the UK and Penn Medicine Biobanks have
already identified numerous ciliary genes and variants significantly associated with glucose and hemoglobin A1c
levels, and demonstrate significant changes in ciliary gene expression in response to insulin. I will further
investigate these associations with two complementary sets of analyses. Specifically, I will (1) use bioinformatic
approaches in large patient datasets to identify and characterize ciliary genes and pathways that confer
increased risk for type 2 diabetes phenotypes and (2) validate these findings in cell models of disease, with a
specific focus on understanding how genetic variation in ciliary genes perturbs the ciliary transport and
downstream signaling of insulin receptor. Through the careful use of cell and molecular biologic approaches
including signaling assays, RNAseq, and live cell imaging, I will quantify differences in insulin receptor signaling
and ciliary transport of insulin receptor when individual ciliary candidate genes, identified in Aim 1, are knocked
down in cell models. The completion of the proposed work will advance our knowledge of cilium biology and
common disease genetics, open new avenues for patient risk assessment, and has the potential to identify novel
therapeutic targets for the treatment of diabetes. Additionally, the application of the methodology and paradigm
developed in this plan will undoubtedly help with the elucidation of multiple other common disease mechanisms
attributable to Mendelian disease genes and cellular processes both within and outside of the cilium.

Public health relevance
PROJECT NARRATIVE The primary cilium acts as the cell’s antenna, with recent evidence suggesting that it is critical to the cell’s ability to respond to signals, such as insulin signaling, that are relevant to the development of diabetes. However, we do not yet know if changes in genes important to ciliary function increase a person’s risk to develop diabetes, nor do we understand how ciliary genes act in the cell to affect insulin signaling. Using a combination of genetic and molecular techniques, this proposal seeks to answer these questions to advance our knowledge of cilium biology, open new avenues for patient risk assessment, and identify novel therapeutic targets for common diseases, like diabetes, with huge public health burdens.